Data Management and Analysis Core

PROJECT SUMMARY
The primary objective of the Sample and Data Management Core (DMAC) is to provide statistical support and
data management and storage capabilities to all components of the University of Louisville Superfund Research
Center (ULSRC). The functions of the Core are matched to the needs of each project and cover a full range of
services from collaboration and routine service to protocol preparation to procedural review and oversight. The
Core will provide two main services: it will establish a repository for the long-term storage and archiving of data;
and it will assist Center investigators in the statistical analysis of their results. The core will assure the authenticity
and quality of these specimens and it will prepare these samples for long-term storage, or dispense samples as
needed. The Core will also provide scientifically valid and rigorous statistical analysis of data and support the
development of innovative methods to enhance the basic and translational research efforts of Center
investigators. It will provide state-of-the-art biostatistics and bioinformatics expertise and analytical support. Core
biostatisticians will also develop new statistical methods, such as quantitative risk assessment models,
multipollutant exposure analysis, and land-use regression models, for estimating cardiometabolic disease risk in
exposed populations and for the analysis and evaluation of exposures and health effects. In collaboration with
other projects and cores, DMAC, statisticians will harmonize the data by defining standards (e.g., creating
searchable data dictionaries and defining variables relevant for each project. In the next funding cycle, we will
continue to use these procedures. The core will serve as a unique educational resource for training graduate
students, post-doctoral fellows, residents and junior faculty and in collaboration with the Training and
Administration Cores. This Core will allow Center investigators easy access to high quality, centralized data
management and statistical services, and thereby will strengthen the organizational cohesion of the Center. This
comprehensive and integrated service permits one or more biostatisticians to be involved from the initial planning
stage of a project (when statistical consultation is most beneficial) throughout its implementation, analysis and
completion. The Core will provide a stable and collegial environment that fosters long-term working relationships
between biostatisticians and investigators, and continues to promote sophisticated approaches to experimental
design and analysis. The biostatisticians of this Core are knowledgeable about clinical research and have broad
expertise in statistical applications for epidemiological investigations, clinical trials, pre-clinical studies, and
prevention and control research. Their interdisciplinary interactions with basic scientists and clinical investigators
will add a new dimension to the interpretation of experimental results, one that is only possible when collaborators
share a mutual appreciation of problems and issues.

Public health relevance
RELEVANCE By ensuring proper study designs and supporting appropriate data analysis, and by providing efficient and organized data management and storage capabilities, the core will further our understanding of risk sources and cardiometabolic disease risk estimation due to exposure to hazardous chemicals. Well annotated data bases, created and supported by the core, will facilitate data sharing and collaborative projects within the Center and with other Superfund Centers and academic institutions.